Metabolic Physiology and Energy Balance Core

METABOLIC PHYSIOLOGY AND ENERGY BALANCE CORE
Project Summary/Abstract
The main function of the Metabolic Physiology and Energy Balance Core is to perform experimental services
to investigate alterations of glucose homeostasis, insulin sensitivity, lipid metabolism and body composition in rodent
models of obesity and insulin resistance.
Increasingly, the biologic roles of gene products and pathways emerging from genomic, proteomic, metabolomic
and other discovery approaches are being queried by generating overexpression, gene knockout or knock-in of
altered genes in rodent models. Thus, there is a growing need for characterization of new mouse models created
by genetic or viral vector technologies. The Metabolic Physiology and Energy Balance Core is designed to meet the
needs for characterization of rodent models that have alterations in glucose homeostasis, insulin action, and/or body
composition and adiposity.
The specific objectives of the Core are to carry out and interpret experiments for Core users aimed at investigating
glucose homeostasis and energy balance. In vivo studies in awake mice include continuous glucose monitoring,
measuring metabolic rates and energy balance by indirect calorimetry and body composition by EchoMRI and DEXA.
Studies in primary adipocytes or adipose explants include glucose transport, metabolism, and lipolysis with
assessment of insulin sensitivity. Services also include the differentiation of stromovascular cells into adipocytes
and assessment of glucose uptake and insulin sensitivity. There is high demand for these services and we anticipate
high utilization.
The Core is actively utilized by BADERC members and other investigators in the Boston area. It enables
investigators from other fields to carry out studies in the area of diabetes and metabolism that may not otherwise be
feasible. Since the inception of the Core, we have received an increasing number of requests for services from
investigators new to the field of metabolism, diabetes and obesity. The Core provides critical support for NIH grants
for both new and established investigators. In many cases, the Core provides the tools that enable experts in other
fields to apply their sophisticated techniques to metabolism research.